Data Lakes Meet the Great Lakes: Deep Dives into Diversity in Genomics

PROJECT SUMMARY
The North Coast Conference on Precision Medicine is a national annual mid-sized conference series held in
Cleveland, Ohio. The conference series aims to serve as a venue for the continuing education and exchange of
scientific ideas related to the rapidly evolving and highly interdisciplinary landscape that is precision medicine
research. The topics for each conference coincide with the national conversation and research agenda set by
national research programs focused on precision medicine. The 2020 and 2021 conferences will be symposia
focused on broad themes relevant to translational genetic and genomic research, including the structure and
biology of genomes; the biology of disease; bioinformatics; computational biology; application of genomics to
improve clinical care; and ethical, legal and social issues (ELISI). All selected symposium topics will include an
emphasis on diverse populations in research, which can range from ascertainment and participant retention
strategies to methods development for analysis of admixed populations. The conference will be organized as a
traditional format with invited speakers from among national experts set in a relaxing and inspiring environment
at the Cleveland Botanical Garden. Specific conference topics are being considered from previous symposia
attendees and trends in precision medicine research. Odd-numbered year conferences include a workshop or
group activity component which has previously covered outcome and exposure variable extraction from
electronic health records and real-time survey of attendee knowledge pre- and post-symposium. Future
workshop topics being considered include integration of multiple ‘omics, drug response in different populations,
pharmacogenomics clinical implementation, precision medicine in cancer, data sharing and informed consent,
and the use of apps for recruitment, diagnosis, follow-up, and treatment. Our second major objective of this
conference series is the promotion of diversity in the biomedical workforce. It is well-known that the pipeline
from training to full professor for women in biomedical research is leaky whereas the pipeline for under-
represented minorities is practically non-existent. Drawing from national and local sources, we vet women and
under-represented minorities for every invited speaker opportunity, thereby providing valuable career currency
and networking opportunities. We will also encourage women and under-represented minorities, particularly at
the trainee level, to attend and participate in this conference series to spur interest in pursuing genetics and
genomics research as a career. Overall, the North Coast Conference on Precision Medicine series is a valuable
addition to the national conference landscape, and with its unique location, low cost to participants, and travel
awards, will serve as an important educational opportunity as precision medicine research accelerates in
earnest.

Public health relevance
PROJECT NARRATIVE The North Coast Conference on Precision Medicine is a yearly fall conference series in Cleveland, Ohio designed as a continuing education forum in the ever evolving area of precision medicine research. The conference brings together national experts on a host of translational genetics and genomic topics ranging from bioethics to bioinformatics to computational biology to speak and lead workshops on timely challenges posed in translating complex genomic and health data into clinical practice. The conference series also serves to promote diversity in the biomedical workforce.